SKIN VIBRATORS AND WEARABLE AIDS FOR THE DEAF-PHASE II

The long-range purpose of this research is to enable the design of better vibrotactile communication aids for the profoundly deaf. The immediate goal is to assess the potential of piezoelectric bimorphs as a means of implementing more appropriate vibrotactile transducers than are available. Theoretical models of various configurations of bimorphs interfacing with the skin will be generated, models validated by measurements and a number of devices built. In order to accomplish these measurements instrumentation for measuring transducer-skin excursions will be built. The relationship between excitations of the type we expect and perceptual thresholds will be established experimentally for use in the model. The performance of different bimorph geometries will be compared in the context of tactile aid requirements and desired types selected for further development. It is expected that we will be able to define very efficient, safe and easy-to-use transducers of the narrow-band type that relate to many tactile aids either being built now or contemplated. Certain other designs require either very small or wide-band transducers. We would expect to gain insight into these types, but not solutions in such a short time. The devices we expect to develop have commercial applications for sale to other designers of tactile aids and as part of aids Audiological Engineering intends to manufacture and sell. According to a communication from N. Durlach of MIT. Working Group 40 of the Committee of Hering, Bioacoustics and Biomedical Devices of the National Research Council concluded that unless better vibrotactile transducers become available, progress of tactile aids would be severely limited. This is our belief also. This research is addressed in the PHS Omnibus Solicitation under NATIONAL INSTITUTE OF NEUROLOGICAL AND COMMUNICATIVE DISORDERS AND STROKE (NINCDS); Communicative Disorders Program; Development of tactile and visual devices for communication in the deaf and deaf-blind."